Standardized Assays for Profiling Antibody Candidates against SARS-CoV2

The objective of this agreement is to provide in vivo efficacy testing of neutralizing antibody products in an animal model of SARS-CoV-2 infection.